Causal inference in infectious disease prevention studies

DESCRIPTION (provided by applicant): The overall objective of this research is to develop statistical methods for quantifying the effects of interventions to prevent infectious diseases. The main motivating examples are studies of vaccine effectiveness. Two particularly challenging problems in vaccine studies entail assessing (i) indirect effects of vaccination and (ii) vaccine effects on post-infection endpoints. Evaluating (i) is a non-standard problem because indirect effects measure the effect of vaccinating one individual on another individual's health outcome. Assessing (ii) is challenging because infected vaccinees may not be comparable to infected controls. This specific proposal is to adapt and develop modern causal inference methodology for use in evaluating (i) and (ii). Similar research will be conducted motivated by studies to prevent transmission of HIV from mother to child where issues similar to (ii) arise. Specific Aim 1 is to develop statistical methods in causal inference with interference for application in evaluating direct, indirect, total, and overall vaccine effects. Areas of particular emphasis will be development of nonparametric tests and confidence intervals, incorporating baseline covariates, and analysis of data from observational studies. A motivating data set is from a trial of cholera vaccines in Bangladesh. Specific Aim 2 is to develop exact statistical methods in causal inference with principal stratification for application in evaluating vaccine effects on post-infection endpoints. This research will focus on applying the ideas of principal stratification in the small sample setting under minimal assumptions. Comparisons will be conducted between the proposed methods and existing large-sample methods as well as traditional intent-to-treat approaches. The research for this aim is motivated by proof-of-concept clinical trials of vaccines where few events are expected. Specific Aim 3 is to develop causal inference methodology to assess vaccine effects on infectiousness. This research will combine aspects of Aims 1 and 2 since studies to assess vaccine effects on infectiousness typically entail conditioning on infection of primary cases (Aim 2) and the vaccination status of the primary case can affect the infection outcome in exposed close contacts (Aim 1). Methods developed in this aims will be used to estimate the causal effect of pertussis vaccination on infectiousness using data from a study in Senegal. Specific Aim 4 is to develop statistical methods for causal inference with principal stratification and competing risks. This research is motivated by studies to prevent postnatal mother-to-child transmission (MTCT) of HIV where HIV-free death and weaning are competing risks. In such studies, investigators are often interested in comparing intervention strategies conditional on survival to a certain time point such that this aim will utilize the principal stratification framework. The methods developed under this aim will be used to estimate the causal effect of antiretroviral therapy on MTCT using data from a recent study in Malawi. 1 PUBLIC HEALTH RELEVANCE: This statistical methods developed in this research will lead to improved estimation of the effects of interventions to prevent infectious diseases. Accurate and precise quantification of intervention effects are important in regulatory decisions and public health policy regarding infectious disease control.

Public health relevance
This statistical methods developed in this research will lead to improved estimation of the effects of interven- tions to prevent infectious diseases. Accurate and precise quantification of intervention effects are important in regulatory decisions and public health policy regarding infectious disease control. 1